Defining the Notch niche for Intestinal Stem cells

PROJECT SUMMARY
This proposal seeks to train a postdoctoral fellow in the experimental technologies and conceptual
knowledge required to become a successful academic researcher in gastrointestinal stem cell
biology. The research proposal aims to elucidate the mechanisms of Notch signaling in immature
and adult intestinal stem cells that regulate both stem cell and Paneth cell maintenance. Notch is
an essential intestinal stem cell (ISC) niche signal that promotes ISC self-renewal to maintain the
stem cell pool. Notch also regulates epithelial cell fate choice, cellular renewal during
homeostasis, and crypt repair after injury, yet the cellular and molecular mechanisms underlying
these processes are poorly understood. Notch signaling requires cell-cell contact and neighboring
Paneth cells are thought to be the Notch niche cells at homeostasis through the expression of
Notch ligands DLL1 and DLL4 on their surface. However, ISCs begin relying on Notch signal
during gestation, well before Paneth cell development, and tolerate Paneth cell loss in the mature
intestine. How the ISC Notch niche is maintained when Paneth cells are absent remains unknown.
Based on my preliminary analysis of ISCs after Paneth cell loss, I hypothesize that in the absence
of Paneth cells, both adult and immature stem cells maintain Notch signaling by juxtacrine
signaling due to ISC expression of the Notch ligands DLL1 and DLL4. This hypothesis will be
tested in Aim 1 to define the Notch niche for ISCs throughout development. Moreover, functional
Notch targets in ISCs as well as crosstalk between ISCs and their niche cells remain
understudied. Our previous studies suggested that Paneth cell maintenance is regulated by an
external, Notch-dependent signal. In Aim 2, I will test the hypothesis that ISCs provide a Notch-
dependent survival signal to the Paneth cells. These aims will harness genetically engineered in
vivo and ex vivo mouse models and employ advanced transcriptomics, cell imaging, and drug
screening approaches. Altogether, this proposal will inform novel therapeutic approaches for
regenerative medicine for the treatment of gastrointestinal diseases, especially those related to
improper intestinal development or dysregulated Notch signaling. I designed these aims to
rigorously test my hypotheses while generating new findings to support my transition to an
independent investigator studying mechanisms underlying intestinal development, plasticity, and
barrier repair. Furthermore, the execution of these aims will allow me to achieve my training goals
in deepening my understanding of gastrointestinal physiology and stem cell biology, and in
mastering state-of-the-art cellular and molecular techniques required to establish my
independence.

Public health relevance
PROJECT NARRATIVE This proposal investigates Notch signaling in intestinal stem cells throughout the development of the intestinal barrier. These aims will inform novel approaches in regenerative medicine for the treatment of diseases caused by improper intestinal development or those presenting with intestinal injury.